Exploiting synthetic lethality to enhance KRAS inhibitor therapy of cancer

PROJECT SUMMARY/ABSTRACT
KRAS is among the most frequently mutated genes in human cancer with most mutations affecting codon
12. KRASG12C (G12C) is especially common in non-small cell lung cancer (NSCLC), comprising ~half of all KRAS
mutations in this disease (~15% of NSCLC overall). Approximately 40% of colorectal carcinoma (CRC) cases
are KRAS-mutated (~10% G12C), while ~1-2% of pancreatic ductal adenocarcinomas (PDAC) have this
mutation. Mutant KRAS had long been viewed as “undruggable”, until pioneering chemical biology and medicinal
chemistry studies resulted first in G12C-specific inhibitors (G12Cis), and later in a plethora of agents targeting
other mutant alleles or even wild type (WT) KRAS and most/all mutants (“pan-KRAS”). Thus far, two small-
molecule G12Cis, sotorasib and adagrasib, have been FDA-approved as second-line agents for NSCLC. While
the magnitude of the conceptual advance provided by G12Cis and other RAS inhibitors (RASi) cannot be
overstated, the clinical response to single-agent G12Cis has been modest. Specific co-mutations (e.g., KEAP1)
can impair the response of G12C-mutated NSCLC, while as single agents, G12Cis have minimal activity in
G12C-mutated CRC. Even when tumors initially respond, resistance emerges rapidly via multiple mechanisms.
Early results suggest that intrinsic and/or emergent resistance will also limit the clinical impact of other RASis.
Whether the same resistance mechanisms will plague other KRAS inhibitors remains unclear, yet what does
seem likely is that durable responses and, ultimately cures, of KRAS-mutated NSCLC will require drug
combinations, potentially including conventional chemoradiation and immune therapies. Rapidly and efficiently
devising such strategies would address a major unmet medical need. We recently reported the results of a
genome-wide CRISPR/Cas9 “dropout” screen for adagrasib synthetic lethal (SL) genes in four (4)
KRASG12C;STK11-co-mutated cell NSCLC lines, three (3) of which are also KEAP1-mutated. We identified ~40
genes that were SL in at least 3 lines, including three (3) serine/threonine kinases (STKs), and ~330 that were
SL in at least two lines. Although our screens focused on SL (i.e., dropout) genes, we also identified 30 enriched
“resistance hits” in at least 2 lines. Functional studies provided initial validation of the three STKs, as well as
ROCK1,2 (which emerged from studies of other recurrent SL genes), but more complete evaluation, including
mechanistic and in vivo efficacy studies, was lacking, as was the applicability of screen “hits” to other G12C
malignancies and other RASis. We propose to tackle these key gaps via a combined biochemical, genetic, and
functional genetic approach. Specfically, we will 1) evaluate four STK family members as SL targets more broadly
and in vivo and clarify the mechanistic basis of synthetic lethality, and 2) use CRISPR/Cas9 “mini-libraries” to
define the synthetic lethality/resistance landscape for G12Cis and other RASis. Our results will address a critical
unmet need in medical oncology by credentialling new targets for RASi combinations.

Public health relevance
PROJECT NARRATIVE Mutations in KRAS are among the most common oncogenic events in cancer. KRASG12C (G12Ci) inhibitors, while promising, lack long term efficacy, and combination strategies are needed to augment their effects in patients and promote more durable responses. To define the landscape of potential combination partners, we will exploit the results of our recently published G12Ci synthetic lethal screen by further credentialing three serine/threonine kinase targets and by using CRISPR/Cas9 mini-libraries to prioritize the remaining hits in the screen across a wider variety of KRAS mutant cell lines.